Novel Approaches to Identifying and Targeting Sepsis-Associated Endothelial Dysfunction

PROJECT SUMMARY/ABSTRACT:
The career development award will support Hilary Faust, MD, MTR, in becoming an independent physician-
investigator focused on identifying mechanisms of sepsis-associated endothelial dysfunction. Sepsis causes
>300,000 deaths a year in the US, predominantly due to sepsis-associated organ failure. Endothelial
dysfunction is a major contributor to organ failure in sepsis, but difficulty accessing human endothelial tissue
and preclinical models that incompletely replicate sepsis heterogeneity hinder development of clinically
available diagnostic tools and targeted therapies. Dr. Faust has developed 2 complementary approaches to
model human sepsis-associated endothelial dysfunction and test candidate therapies without risk to critically ill
patients. Her endothelial microphysiological system (MPS) replicates sepsis plasma-associated endothelial
dysfunction, while capture of circulating endothelial cells (CECs) from sepsis patients allows direct study of
endothelial sepsis responses. To maximize insights from these approaches, Dr. Faust has set two career
development goals: (1) master advanced human endothelial injury techniques using MPS and CEC capture
and (2) gain transcriptomic expertise to identify novel endothelial dysfunction mechanisms. Dr. Faust will
pursue these objectives through a 5-year career development plan involving structured didactics, experiential
research, and intensive mentoring. Dr. Faust will be mentored by Dr. Lynn M. Schnapp MD, a physician-
scientist with expertise in basic science investigations of lung injury and repair, with an outstanding record of
mentorship and co-mentor Dr. Nuala J. Meyer, MD MTR, an expert in molecular phenotyping of sepsis patients
who has mentored Dr. Faust for >6 years. Dr. Faust's career development will be supported by the exceptional
institutional environment of the University of Wisconsin and strong research infrastructure of the Schnapp
Laboratory and the team of mentors and collaborators. These skills will allow Dr. Faust to expand her research
focus from her previous work identifying the association of mitochondrial DNA (mtDNA) with sepsis-associated
organ failure to explore endothelial mtDNA signaling via Toll-like Receptor 9 (TLR9). By testing inhibition of
TLR9 in the endothelial MPS, she will define the potential of this promising candidate pathway as a therapeutic
target for sepsis-associated organ failure (Specific Aim 1a). She will also use the MPS to identify 1b) novel
mechanisms of sepsis plasma-induced endothelial dysfunction using RNAseq. In Aim 2, she will capture CECs
cells and perform the first detailed phenotyping of CECs in human sepsis through imaging flow cytometry and
RNAseq. This will provide previously inaccessible insight into endothelial sepsis responses and determine
whether CECs can serve as a noninvasive surrogate for evaluating endothelial injury. Ultimately, the career
development activities and support of the NIGMS K08 will enable Dr. Faust to become a leading translational
sepsis investigator committed to identifying effective, direly needed targeted therapies for sepsis patients.

Public health relevance
PROJECT NARRATIVE Endothelial dysfunction is a major factor in sepsis-associated organ failure, which is the leading cause of sepsis-related deaths. This study aims to develop targeted therapies for endothelial dysfunction using advanced human cellular sepsis models, including an endothelial microphysiological system and analysis of circulating endothelial cells from sepsis patients. By performing RNA sequencing on these cells, we hope to identify new mechanisms contributing to endothelial dysfunction and organ failure, paving the way for targeted treatments for sepsis.